Clonal hematopoiesis, epigenetic changes, social determinants of health, and behavioral risk factors as predictors of accelerated aging in HIV

SUMMARY
Effective antiretroviral therapy (ART) has dramatically reduced mortality, therefore people with HIV (PWH) are
now surviving into middle and old age. Despite this success, PWH experience high rates of multimorbidities, and
functional and cognitive decline at a younger age than those without HIV, a phenomenon known as accelerated
aging. Thus, there is an urgent need to focus not just on mortality but on healthspan, or the time someone is
healthy not just alive, by defining the drivers of the accelerated aging. Epigenetic clocks are powerful tools for
predicting aging-associated diseases and lifespan in the general population; however, there are little data on the
effects of HIV and ART on epigenetic aging in older PWH. More recently, clonal hematopoiesis, a noncancerous
expansion of a somatic blood cell clone, of indeterminate potential (CHIP) has been shown to be associated with
increased risk for hematological cancers, cardiovascular (CVD) and pulmonary diseases, obesity, osteoporosis,
and all-cause mortality, in the general population. Importantly, the prevalence of CHIP is much higher and onset
earlier among PWH. Moreover, CHIP has been more commonly identified in PWH with CVD, sometimes years
before CVD diagnosis. However,
data are lacking on its contribution to other age-related outcomes in PWH.
Moreover, the modifying effects of underlying genetic predisposition, socio-behavioral aspects and other HIV-
specific risk factors are largely unknown limiting our ability to prevent or slow down functional and cognitive
decline and multimorbidity. CFAR Network of Integrated Clinical Systems (CNICS) is a large, well-characterized,
prospective gender, and racially/ethnically diverse cohort with ~49,000 PWH. CNICS captures rich longitudinal
clinical data, patient-reported measures and outcomes, health-related quality of life (HRQL), and additional social
determinants of health factors, and provides access to a biospecimen repository. We will leverage and build on
the extensive platform and data collection of CNICS to identify the drivers of accelerated aging. We hypothesize
that the interplay of epigenetic changes and CHIP with genetic predisposition and HIV-specific and socio-
behavioral factors drive functional and cognitive decline, multimorbidity, and mortality among PWH. In Aim 1, we
will establish a sub-cohort from 6,442 already enrolled PWH ages ≥50 years with existing biospecimens and
prospective clinical data and determine the role of the epigenetic aging, genetic predisposition, and socio-
behavioral factors in functional and cognitive decline, osteoporosis, multimorbidity, HRQL, and morbidity in PWH.
In Aim 2, we will generate whole exome sequencing data to identify specific CHIP-driving mutational patterns
that define different risk of developing adverse age-related outcomes and explore the interplay between CHIP
and epigenetic changes in PWH. In Aim 3, we will use Mendelian randomization to detect the causal effect of
epigenetic aging and CHIP on age-related diseases and identify potential drugs that may reverse adverse
outcomes. Understanding the predisposition to and the impact of accelerated aging is critical to identifying PWH
at high risk, developing preventive and therapeutic strategies, and improving the healthspan in the setting of HIV.

Public health relevance
NARRATIVE Longevity antiretroviral among persons with human immunodeficiency virus (PWH) has increased dramatically due to effective therapy yet,; PWH experience higher rates of the consequences and morbidities of aging often at a younger age than those without HIV. We propose to leverage a large well-characterized prospective cohort of PWH in care with access to biospecimens and extensive clinical data and social determinants of health factors to explore how the interplay of epigenetic aging and clonal hematopoiesis of indeterminate potential (CHIP) with genetic predisposition and HIV-specific and socio-behavioral factors drive functional and cognitive decline, multimorbidity, and mortality among PWH. Identifying causal modifiable factors leading to age-related adverse events will help develop novel strategies for prevention and early intervention in PWH.